Laboratory Flexible Funding Model (LFFM) Indiana Department of Health

OVERALL PROJECT SUMMARY
Indiana Department of Health (IDOH) Laboratory will assist the FDA with a prevention-based
approach to monitoring the safety of the food supply through increasing food product analysis.
IDOH Laboratories is a multidisciplinary team specializing in environmental and clinical testing
for biological and chemical adulterants. Tracks in the Microbiology Discipline are being
completed by the IDOH Food Microbiology Lab, IDOH Enterics Lab, and IDOH Biological Threat
(BT) Lab. Tracks in the Chemistry and Radiochemistry Disciplines are being completed by the
IDOH Food Chemistry Lab, and IDOH Radiochemistry Lab, with assist from the Organics,
Chemical Threat and Metals Lab. Each department has the training and experience to
complete routine testing in their respective lab areas as required in this cooperative agreement.
For method validation and capacity development projects, these departments plan to work
together using their respective expertise to tackle unfamiliar matrices, methods, and/or analytes
to complete the projects.

Public health relevance
OVERALL PROJECT NARRATIVE The Cooperative agreement with Indiana Department of Health (IDOH) Laboratory will focus on a prevention-based approach to monitoring the safety of the food supply by increasing surveillance. The IDOH laboratory also will respond to food-based health threats for food defense.